VIETNAMESE WOMEN'S CANCER SCREENING PROJECT

The hypothesis of this project is that breast and cervical cancer screening rates of Vietnamese women can be increased through an active intervention that identifies and addresses the barriers to cancer screening.